Identification of genes conferring susceptibility in a preclinical model of PTSD

PTSD is recognized as one of the “invisible” wounds of war. Military figures report rates
ranging from 13 to 30% lifetime prevalence amongst service members returning from combat
zones. Within this group, combat exposure produces a virulent form of PTSD that is refractory to
current treatment, and remission of symptoms is reported in only very few patients. There is
therefore a pressing need to advance our current understanding of the underlying neurobiological
responses to trauma in much greater depth and detail than previously.
It remains unknown why only a fraction of patients exposed to traumatic events develop
PTSD. Delineating risk and resiliency factors could provide clues to better understand the
mechanisms driving resilience and susceptibility to stress exposure and thus lead to the
development of tailored preventative interventions.
One method of tackling this is to use single cell transcriptomics to identify disease
associated neural cell subpopulations and their transcriptomic profiles that drive clinical traits.
Conducting such studies in humans carries several inherent challenging problems. Thus, our
approach to this problem is to utilize a clinically relevant, well characterized laboratory model, in
which many variables can be controlled. We have developed and characterized a unique mouse
model of exposure to multiple stressors that results in acute and, most importantly, chronic
behavioral and neuroendocrine changes, recapitulating findings in human PTSD patients. Like
humans, our model displays a notable heterogeneity in response to stress, with some mice
demonstrating little effect of the stress exposure, while others are severely compromised.
In this proposal, we will use a single cell transcriptomic approach in our mouse model of
stress exposure to identify disease associated neural cell subpopulations and their key regulatory
genes that function as a molecular switch driving susceptibility to stress. We will expose a large
cohort of mice to our stress paradigm and perform behavioral assessments to discriminate
between high (susceptible) vs low (resilient) responding mice. We will employ an unbiased
scRNAseq mining approach to interrogate single cell transcriptomic profiles in the amygdala,
hippocampus and medial prefrontal cortex that drive behavioral phenotypes in high vs low
responding mice. From this molecular library of transcriptomic responses, we will identify the
candidate upstream regulators driving the neurobiological changes involved in susceptibility to
stress. In future studies we will map our single cell (mouse) transcriptomic data with our
collaborator’s human transcriptomic database of PTSD cases, and confirm translationally relevant
mouse gene hits by intersection with human PTSD genes identified from autopsy tissue.
Candidate genes, representing molecular drivers, will undergo successive interrogation for their
functional and therapeutic roles at multiple levels. Validation in primary cell cultures and in vivo, will
assess the impact of their silencing or overexpression in promoting stress responsive molecular
pathways and behavioral susceptibility. The most promising genes will be selected, for in vivo
therapeutic target validation in our model using adeno-associated virus therapy.
The overarching goal of this proposal is to capitalize on our translationally relevant mouse
model to identify candidate novel therapeutic targets in PTSD. This work will provide a foundation
for further validation and IND-enabling studies of well rationalized approaches, designed to
address the growing population of PTSD patients suffering from this highly debilitating disorder.

Public health relevance
PTSD is referred to as an invisible wound of war, but only a proportion of returning service members from combat zones go on to develop the disorder, and we do not understand the factors which determine resilience or susceptibility. We have developed a mouse model of stress exposure, which recapitulates some PTSD-like phenotypes that persist for many months, and in which, following the same stress exposure, we observe variable response, as seen in humans. In this proposal, we will use a single cell transcriptomic approach to identify and interrogate neural cell subpopulations and genes that drive low (resilient) and high (susceptible) responding traits, after exposure to our stress paradigm. These candidate genes will be validated in future studies by confirming their relevance in an existing human transcriptomic database and evaluating their functional and therapeutic roles in preclinical and clinical PTSD.